SensiTrak: Automated Assessment of Forelimb Sensation

Project Abstract In this Phase I STTR project, Vulintus, Inc., in collaboration with Columbia University, proposes to develop and test ‘SensiTrak,’ an automated, high-throughput behavioral system designed to finely measure somatosensory function in rodent models. Current common methods for measuring somatosensory function in rodent models generally rely on withdrawal responses to uncomfortable or painful stimuli. These tests can be stressful to the animal, while also yielding a high variability in measured responses, and repetitive testing in longitudinal models may even result in chronic pain states. To better understand the connection between physiology and perception of touch and proprioception, researchers need a modern, off-the-shelf assessment system to administer and quantify trained, volitional behaviors. SensiTrak will meet these needs by supporting complex, electromechanical feedback interactions with animals, with interchangeable task modules, behavioral peripherals, and open-source behavioral software. Phase I work will focus on finalization and bench testing of the SensiTrak prototype design and validation testing with a rat model of somatosensory-specific impairment.

Public health relevance
Project Narrative Current methods of assessing somatosensory function in animal models largely depend on withdrawal responses to uncomfortable or painful stimuli, which does not translate well to more clinically relevant tests of touch and proprioception. In this Phase I STTR project, Vulintus, Inc., in collaboration with Columbia University, proposes to develop and test ‘SensiTrak,’ an automated, high-throughput operant behavioral system designed to finely measure somatosensory function in rodent models.